2022 Microbial Toxins and Pathogenicity Gordon Research Conference and Seminar

Project Summary The 2022 Microbial Toxins and Pathogenicity Gordon Research Conference (GRC) and its accompanying Gordon Research Seminar (GRS) “Intercellular Interactions and Pathologic Outcomes” are designed to showcase exciting, innovative basic and applied research in the infectious disease fields while promoting intensive discussion and networking between new and veteran researchers from academia and government, medicine and biotech. Since its inception in 1972, this biennial international conference continues to be regarded by the microbial pathogenesis community as our premier venue for intellectual exchange. To be held July 10-15 at Waterville Valley Conference Center in New Hampshire, the 2022 Conference is led by Chair K. Heran Darwin, PhD, Professor in the Department of Microbiology at New York University Langone Health, and Vice Chair Mary X. O'Riordan, PhD, Professor of Microbiology at the University of Michigan. Nine sessions will feature 31 invited speakers (plus four from the GRS), chosen to integrate cutting-edge research on: bacterial toxins, pathogen physiology, new approaches to study pathogens, pathogen encounters with host cells, and how pathogens trigger and respond to innate immune responses. To highlight current challenges in each of these areas and to stimulate provocative exchange among junior and senior attendees, the nine Discussion Leaders will present 10-minute session introductions and lead 10-minute discussion periods after each talk. Afternoon poster sessions will promote extended discussions between colleagues within and across disciplines and ranks. To integrate and develop the next generation of scientists in our field, the GRC will be preceded by a GRS. The GRS is planned, led and attended exclusively by pre- and post-doctoral trainees who then join the Conference. Together the Seminar and Conference promise to provide an exceptional forum for a diverse population of scientists to learn about cutting edge discoveries in the field, and consider and challenge the current paradigms, barriers and opportunities to advancing knowledge of molecular mechanisms of microbial pathogenesis.

Public health relevance
Project Narrative The 2022 Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on Microbial Toxins and Pathogenicity are the premiere events that showcase exciting, innovative basic and applied research in the field of infectious diseases. The GRC and GRS promote open discussions and active networking between new and veteran researchers from academia and government, medicine and biotech. In addition to providing an exceptional forum for a diverse population of scientist to learn and discuss the latest discoveries in the field, the GRC and GRS provide exceptional opportunities for the professional development of the next generation of scientists and facilitates their integration within the broader community.